Delaware INBRE

PROJECT SUMMARY/ABSTRACT
The aim of this project is to acquire a Particle Metrix ZetaView QUATT to characterize small vesicles and
particles by nanoparticle tracking analysis (NTA). The University of Delaware (UD) Bio-Imaging Center and its
satellite Flow Cytometry Core currently provide nanoparticle characterization of extracellular vesicles (EVs),
viruses, virus-like particles, and other nanoparticles used for drug delivery with electron microscopy and flow
cytometry. These approaches are invariably complemented and/or validated by NTA to determine size
distribution, concentration, and zeta-potential. Despite the ubiquity of the NTA approach, there are currently no
NTA systems in a fee-for-service core facility in Delaware. This project aims to fill this critical gap in capabilities
by placing the ZetaView NTA system in the UD Bio-Imaging Center, which will ensure that it is easily
accessible and well-maintained by core facility staff scientists. Bio-Imaging Center staff will also train users
how to run their own samples on the ZetaView and also provide NTA on the ZetaView as an “add-on” service
for individuals submitting EV or nanoparticle samples for electron microscopy and flow cytometry services.
Therefore, the ZetaView will directly complement recent investments in these technologies and further advance
our ability to support research on EV release in bone marrow cells, cancer cells, pathogenic microbes, and
nanoparticles developed from viruses, assembled peptides, and fabricated nano-vesicles.

Public health relevance
Project Narrative All living organisms produce and release small extracellular vesicles. In humans, they have been implicated in cell-to-cell communication and pathological conditions such as neurodegenerative and cardiovascular diseases and cancer progression. This project seeks to acquire a device to measure size, amount, and surface properties of extracellular vesicles and other types of small nanoparticles. The device is a critical tool for researchers using the presence of extracellular vesicles as a diagnostic indicator for disease and co-opting extracellular vesicles or synthetic nanoparticles to deliver therapeutics.